Chelators to Enable Theranostic Alpha Particle Radiotherapeutic Agents

PROJECT SUMMARY
Targeted internal radionuclide therapy is a highly efficacious form of cancer treatment that employs
administered radiopharmaceutical agents to destroy malignant cells. Radiopharmaceutical agents of this type
require a biological targeting vector, which selectively recognizes and binds to receptors that are
overexpressed on cancer cells, and a bifunctional chelating agent, which stably binds to and attaches the
radionuclide to the targeting vector. The radionuclide can be chosen and altered to possess different nuclear
decay properties, potentially rendering it valuable for theranostic applications, as long as its coordination
chemistry is compatible with the bifunctional chelator. Conventionally, beta particle emitters have been
leveraged for therapeutic applications, but recent clinical studies have revealed the efficacious nature of alpha
particle emitters for this application. The use of alpha emitters is hindered, however, by a lack of gamma
photon or positron emissions that can be leveraged for theranostic applications and by their unconventional
coordination chemistries, making it challenging to find a suitable bifunctional chelator. This project will address
both of these challenges in alpha particle emitter targeted internal therapy by designing new bifunctional
chelators that can be simultaneously used with diagnostic gamma- or positron-emitting radionuclides. In
Specific Aim 1, new bifunctional chelators for the established highly promising alpha emitter actinium-225 will
be developed. These chelators will be designed so that they can also effectively accommodate the widely
available imaging radionuclide indium-111. With these new chelators, theranostic agents based on actinium-
225 can be easily accessed. Specific Aim 2 will focus on the short-lived alpha emitters lead-212 and bismuth-
213. To make theranostic agents from these radionuclides, bifunctional chelators that can be easily
functionalized with the versatile positron-imaging radionuclide fluorine-18 will be synthesized. Lastly, in Specific
Aim 3, chelators for the unconventional newly arising radionuclides uranium-230, and vanadium-48 will be
developed. Uranium-230 is a therapeutic alpha emitter and vanadium-48 is a diagnostic positron emitter. We
will explore chelating agents that are mutually compatible for these radiometals to enable their use as a
theranostic pair. Through these three aims, this work will increase the diversity of radionuclides with distinct
half-lives and decay chains that can be used for this application. Furthermore, it will give rise to diagnostic
partners for these therapeutic alpha emitters, which is critically important for predicting patient dosimetry,
disease staging, and response. Collectively, the successful execution of this project will give rise to theranostic
alpha-emitting therapeutic agents that can cure and diagnose human disease.

Public health relevance
PROJECT NARRATIVE Internal targeted radionuclide therapy uses radioactive drugs to destroy tumors and can also be applied for imaging or diagnostic applications. From a therapeutic perspective, those that emit a specific form of radiation called alpha particles are highly effective and have been the subject of many promising clinical trials within recent years, but are generally not amenable for imaging. This project will develop new chemistry to enable the highly efficacious alpha-emitting drugs to be used in conjunction with identical radioactive imaging agents, leading to substantial improvements in patient treatment and diagnosis.